Modifier of Cancer Sensitivity to Statins

? DESCRIPTION (provided by applicant): We have recently discovered an unexpected connection between a critical lung cancer gene termed thyroid transcription factor 1 (TTF-1 also known as NKX2-1) and cholesterol metabolism. By searching for downstream target microRNAs of TTF-1, we found that TTF-1 upregulates miR-33a which is known to be critical for cholesterol regulation by suppressing ATP-binding cassette transporter 1 (ABCA1) and its associated cholesterol efflux function. Thus, we set out to demonstrate that a higher TTF-1 expression would presumably inhibit cholesterol efflux and raise intracellular cholesterol level. Surprisingly in our preliminary studies we found that raising TTF-1 expression actually lowers intracellular cholesterol level, which we believe is attributed to our discovery that TTF-1 directly transactivates ABCA1. In view of the fact that cholesterol is essential for cell viability, we surmised that lung cancer cells primed with a TTF-1-driven decrease of cholesterol would be sensitized to cholesterol biosynthesis inhibitors. Indeed, enforced expression of TTF-1 in human lung cancer cells enhanced cellular sensitivity to statins, a frequently prescribed medication to lower systemic cholesterol. Under Aim 1, we plan to comprehensively characterize the functional requirement of ABCA1 for the enhanced statin sensitivity of cells with TTF-1 overexpression. Subsequently, under Aim 2 we wish to use both orthotopic and anonymized patient-derived lung cancer model systems to test the efficacy of statins against TTF-1+ lung adenocarcinomas. Given the fact that pathologists routinely interrogate human lung cancers for TTF-1 immunopositivity to guide diagnosis and the prevalent use of statins, the outcome of this study will inspire translational and clinical research to improve lung cancer management.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have uncovered a completely novel link between a critical lung cancer gene termed Thyroid Transcription Factor 1 (TTF-1 also known as NKX2-1) and cholesterol metabolism. An important implication of this finding that TTF-1+ lung cancers may be more sensitive to cholesterol-lowering medications will be comprehensively investigated in this study.